Center for Multiomic Human Brain Cell Atlas

Abstract
Understanding cell identities and their spatial distributions throughout different regions of the human brain is a
fundamental step when trying to integrate physiological, behavioral, neurochemical and molecular data. At
present, although major categories of the cell-types present in the human brain have been defined molecularly,
the different subtypes within these categories along with their locations are far from understood. Gene expression
drives cell programs and states that underlie distinct brain functions. Open chromatin and modified histones
mark gene-regulatory elements that control cell type-specific gene expression patterns. Cytosine DNA
methylation (mC) is a stable epigenomic signature that persists in post-mitotic cells throughout their lifetime,
defining their cellular identity. Single-cell gene expression, open chromatin profiles and DNA methylation assays
have been successfully used to identify distinct cell types in an unbiased fashion in heterogeneous tissues
including the human brain. This UM1 proposal builds on our earlier successes in mouse brain mapping to
produce detailed single-cell multimomic and spatial cell maps at the single-cell level across 100 anatomically
defined regions in the human brain. Profiling human brain samples will permit the discovery of unique gene
expression patterns for each molecularly-defined cell type, identify their spatial organization, and their specific
non-coding DNA regulatory regions. Multi-modal integration between epigenomic and transcriptomic signatures
will allow the identification of new cell types and unique cell-type markers that will rapidly be made available to
the entire community. This UM1 project will also provide new tools for genetic access of previously inaccessible
brain regions as well as facilitate the functional analysis of genetic variants associated with neuropsychiatric and
neurological disorders.

Public health relevance
PROJECT NARRATIVE Brain functions arise from complex networks of many different types of cells connected in neural circuits. The goal of this UM1 project is to map the identities and compositions of the many different kinds of cells in various regions of the human brain. Determining the molecular properties and locations of cells from a diverse population of human brain samples will aid in our understanding of normal human brain functions and the underlying mechanisms of a variety of human neurological and neuropsychiatric diseases.